EFFECTS OF DIETARY SUPPLEMENTS WITH TRIOSE COMPOUNDS IN NONINSULIN DEPENDENT DM

Examination of the mechanism(s) whereby triose compound supplements may lower plasma glucose and increase muscle glycogen content.